Probing the activity of DUX4 in FSHD

PROJECT SUMMARY
Facioscapulohumeral muscular dystrophy (FSHD) is a genetically dominant progressive muscular dystrophy
associated with inappropriate expression of the DUX4 gene. FSHD afflicts over 25,000 individuals in the United
States, is a very common genetic disease, and is currently without treatment. In the previous cycle of this renewal
application, we discovered that DUX4 gene expression is self-limited to short bursts of activity, with the DUX4
target gene DUXA serving as a feedback inhibitor, and a degron in the C-terminus leading to protein instability.
We also discovered that transient DUX4 expression in muscle fibers in our iDUX4pA doxycycline-inducible
mouse model tips muscle into an injury-sensitive pro-fibrotic state mediated by long-term changes to the FAP
compartment, and developed a p300-specific inhibitor, iP300w, for treating DUX4-induced disease, including
finding that iP300w inhibits CIC-DUX4, a fusion oncoprotein that causes a very aggressive pediatric sarcoma.
The renewal application builds on this work, with a series of studies aimed at continuing to explore the molecular
mechanism of DUX4 activity by understanding the function of proteins that interact with DUX4 including those
that degrade it, developing p300 inhibition as a therapeutic approach, and investigating pathological mechanisms
underlying DUX4-mediated skeletal muscle disease using transient and cell type-restricted expression of DUX4
in the iDUX4pA mouse model.

Public health relevance
PROJECT NARRATIVE Facioscapulohumeral muscular dystrophy (FSHD) a genetically dominant progressive muscular dystrophy associated with inappropriate expression of the DUX4 gene. This application focuses on understanding the DUX4 protein mechanistically, on testing a new therapeutic intervention targeting the ability of DUX4 to turn on downstream gene expression, and to study mechanisms of fibrosis and muscle degeneration in a mouse model based on controlled DUX4 expression in muscle fibers or fibroblasts. This work thus helps us understand the disease and also has the potential to lead to therapies for FSHD based in inhibiting DUX4 activity.